Mechanisms of homologous recombination in yeast

DESCRIPTION (provided by applicant): DSBs are highly cytotoxic lesions that occur spontaneously during normal cellular processes, by treatment of cells with DNA damaging agents or as intermediates in programmed recombination events. If DSBs are left unrepaired, or repaired inappropriately, they can trigger mutagenic events including chromosome loss, deletions, duplications, inversions and translocations, events associated with tumorigenesis. The long-term objective of our research program is to understand how cells repair DNA double strand breaks (DSBs) to maintain genome integrity. The focus of the current proposal is the mechanism and regulation of 5'-3' end resection, which has emerged as a key regulatory step to govern repair pathway choice, and is the critical first step for homology-directed repair of DSBs. While much progress has been made in the identification of the key components of the end resection machinery, the mechanism of resection initiation is still in question. The first aim of te proposal is to define the roles of Sae2 and Xrs2 in MRX complex functions. We identified several mre11 gain-of-function alleles, mre11-sas, that can bypass the DNA damage sensitivity of the sae2Δ mutant by extinguishing the DNA damage checkpoint. We plan to investigate the dynamics of MRX association with DNA ends in vivo and by single-molecule imaging, and determine the dependence on other components of the DNA damage checkpoint for suppression of sae2Δ by the mre11-sas alleles. The role of Xrs2 in the cellular response to DNA damage will be dissected using an MRE11-NLS fusion that bypasses the requirement for Xrs2 to transport Mre11 to the nucleus. The exonuclease-defective mre11-H59S allele will be used with sgs1Δ and exo1Δ mutations to test the model that resection initiates by a nick internal to the DNA ends. The second aim follows up on our interesting new finding that RPA prevents repair of DSBs by microhomology-mediated end joining (MMEJ). This mutagenic repair mechanism is thought to be responsible for chromosome rearrangements in cancer cells. We will investigate the roles of RPA and Sae2 in suppression of chromosomal inverted duplications mediated by annealing between short inverted repeats. The final aim is to understand how the DNA damage checkpoint regulates end resection. The ssDNA formed by end resection is important to activate the DNA damage checkpoint; however, excessive ssDNA is detrimental to genome integrity and several studies indicate that the DNA damage checkpoint prevents extensive resection. We will identify the resection nucleases inhibited by Rad9 during the cell cycle and dissect the functions of Rad9 responsible for inhibition of end resection. Finally, the role of the DNA damage clamp in promoting or inhibiting end resection will be tested in the presence or absence of Rad9.

Public health relevance
PUBLIC HEALTH RELEVANCE: The repair of DNA double-strand breaks (DSBs) is essential to maintain genome integrity and to guard against cancer in humans. In this proposal, genetic and physical approaches will be used to determine the roles of Sae2/CtIP in regulating the nuclease and checkpoint responses of the Mre11 complex, the role of RPA in suppressing genome rearrangements, and how the DNA damage checkpoint regulates the mechanisms used to repair DSBs.